Gvl mHA Specific T Cell Responses Prevent AML Relapse Following Allogeneic Stem Cell Transplantation.

Abstract
We plan to extend the initially proposed work in three ways. First, we will extend our alloantigen identification from
considering only antigens derived from germline single-nucleotide polymorphisms (i.e. classical mHAs) to those derived
from large structural variants (germline and somatic) along with small somatic variants and tumor-specific transcriptional
variants (e.g. alternative splice variants, cancer/testis antigens, endogenous retroviral antigens). Our goal is to capture the
full landscape of alloantigens that may be targeted by donor-derived T cells in alloSCT, which will allow us to more
comprehensively map the antigen-specific T cell response following HLA-matched alloSCT. This will allow us to
evaluate by immunopeptidomics studies and measure T cell responses to as broad a set of antigens as possible, to better
understand the landscape of T cell responses following alloSCT (and how these associate with relapse-free survival). We
will assess the clonal heterogeneity of antigen expression using long-read single cell sequencing, to test the hypothesis
that antigen-specific T cell populations that cover a larger proportion of tumor subclones will be associated with better
relapse-free survival. Finally, we will extend our work on testing associations between mHA features and specific mHA
with clinical outcomes following alloSCT. Using a large dataset of alloSCT DRP genome and transcriptome being
generated by the DISCOVeRY-BMT group, we will integrate genome-wide mHA identifications with KIR/KIR ligand
information as predictor variables and test statistical learning and deep learning strategies to improve clinical outcomes
prediction. We will accomplish these extensions of the initially proposed work in the following specific aims:
Aim 1: Evaluate the contribution of large structural variants to the pool of immunogenic graft-versus-leukemia
mHA in the context of HLA-matched allogeneic stem cell transplantation.
Aim 2: Comprehensively map the MHC class I-restricted alloantigen landscape of AML in the context of HLA-
matched allogeneic stem cell transplantation.
Aim 3: Adapt our methods for antigen discovery to identify alloantigens targeted by CD8+ T cells in haploidentical
allogeneic stem cell transplantation.
Aim 4: Integrate data from mHA profiling with NKc genetics profiling to improve prediction of alloSCT outcomes.

Public health relevance
PROJECT NARRATIVE Allogeneic hematopoietic stem cell transplantation (alloSCT) is a curative therapy for high-risk acute myeloid leukemia (AML); however, alloSCT suffers from substantial treatment related toxicity and a high frequency of disease relapse. It is likely that AML is cured post-SCT due to donor immune cells targeting minor histocompatibility antigens (mHA) presented by patient leukemia cells. This research proposal will investigate the magnitude of donor immune targeting of leukemia associated mHA and other tumor antigens along with mechanisms of resistance active in AML, which could lead to improved SCT outcomes.